Biochemical mechanisms of beta cell protection through bromodomain inhibition

PROJECT SUMMARY
Type 1 diabetes (T1D) is an autoimmune disease characterized by insulin deficiency resulting from reduced
function and progressive loss of insulin-producing pancreatic β-cells. Although many T-cell-dependent
mechanisms underlie T1D progression, the role of the β-cell responses in promoting autoimmune inflammation
is poorly understood. Our long-range goals are to determine the role of the three ubiquitously expressed
bromodomain and extraterminal (BET) family members (BRD2/3/4) in β-cell transcriptional responses to
inflammation associated with autoimmune diabetes. Each BET protein contains two bromodomains, which are
epigenetic ‘readers’ of lysine acetylation on histones and transcription factors, and bromodomain binding to
acetylated histones/proteins regulates transcription in a gene- and cell-type dependent manner. Interestingly,
pan inhibitors that equally target both bromodomains of all BET proteins elicit broad anti-inflammatory effects
and delay diabetes onset in the non-obese diabetic T1D mouse model. However, the direct effects of BET
bromodomain inhibitors on the function and viability of β-cells are largely unknown. We hypothesize that β-cell
inflammation (Aim 1) and identity (Aim 2) can be regulated by selectively inhibiting BET proteins in a
bromodomain- and cell-type-specific manner. Broad inhibition of all BET bromodomains and the inability to
directly target specific cell types are significant challenges, and such broad inhibition is associated with dose-
limiting toxicities and adverse effects. We will address these limitations by evaluating the transcriptional actions
of next-generation BET bromodomain inhibitors that are selective for a subset of BET bromodomains (Aim 1
and 2) and develop innovative methods to selectively target BET bromodomain inhibitors to β cells (Aim 3).
Completing these aims will uncover the precise gene- and cell-type-specific mechanisms by which BET
bromodomain inhibition modulates β-cell transcription, inform the development of next-generation β-cell
targeted inhibitors, and advance T1D treatment and β-cell replacement strategies.

Public health relevance
PROJECT NARRATIVE In autoimmune diabetes, a person’s immune system kills insulin-producing beta cells in the pancreas, which makes the pancreas unable to produce insulin to control blood sugar levels. The reasons people develop autoimmune diabetes are not entirely known, but the cause goes beyond a family history of diabetes. This proposal aims to determine how specific beta cell proteins control changes in genetic programs that promote beta cell health or disease and to create new drugs and cells that promote beta cell health.